Developing Natural Products to Target IL-8 Signaling and Intercept Progression of Barrett’s Esophagus to Esophageal Adenocarcinoma

PROJECT SUMMARY/ABSTRACT
Esophageal adenocarcinoma (EAC) is a growing health problem characterized by rising incidence, substantial
morbidity, and poor prognosis (5-year survival rates <20%) supporting the urgent need for improved strategies
for prevention and interception. The only precursor lesion to EAC is Barrett’s esophagus (BE), a metaplastic
protective adaptation to chronic reflux of injurious bile salts and acidic gastric contents, known as
gastroesophageal reflux disease (GERD). Acid-reducing proton pump inhibitors (PPIs) are the mainstay of
treatment for GERD, yet widespread use of PPIs has not translated into meaningful declines in EAC. Thus, our
long-term goal is to identify non-toxic efficacious natural products to intercept BE progression to EAC by targeting
the major drivers and sequelae of BE. Reflux components stimulate cytokine-chemokine mediated inflammation
in the esophagus contributing to epithelial injury, immune cell migration, genetic instability and EAC progression.
Multiple lines of evidence support that IL-8, a proinflammatory and immune suppressive chemokine, is an early
and key driver of BE progression to EAC. We and others have documented a step-wise increase in IL-8
expression from normal through BE to EAC. We identified elevated levels IL-8 and its receptors in a BE cohort
with high-grade dysplasia (HGD) or EAC compared to low-grade dysplasia (LGD). IL-8 signaling was identified
in >60% of pathway maps upregulated in BE.HGD. Deconvolution analysis revealed an immune suppressive
environment with BE progression, showing activation of neutrophils in BE.HGD versus BE.LGD. Our findings
align with a comprehensive report pinpointing altered IL-8-neutrophil signaling as an early driver of BE to EAC
progression and one intriguingly linked to a racially influenced immunological basis for esophageal cell
transformation. Finally, circulating levels of IL-8 are elevated in BE and EAC and correlate with poor patient
prognosis. Based on the published literature coupled with our unpublished data we hypothesize that inhibiting
IL-8 signaling by natural products can be exploited as a promising strategy to intercept BE progression to EAC.
In collaboration with NCATS, we propose to screen the NCI’s natural product (NP) library and identify top hits
targeting IL-8 through three aims. Aim 1 studies focus on IL-8 HTS assay optimization, initial NP screening and
dose determination in BE.HGD cells. Aim 2 will first, employ orthogonal and counter assays to eliminate false
positives and interference NPs and screen for toxicity in the top 20 on-target hits in normal, BE and EAC cell
lines and second, characterize and validate NPs in patient derived models utilizing pharmacologic and genetic
approaches. Aim 3 evaluates the pharmacokinetics/dynamics of five lead NP hits via microsomal stability testing,
plasma stability determinations and in vivo rodent studies to estimate half-life, drug clearance and oral
bioavailability culminating in a cancer prevention bioassay. This research holds strong potential to identify new
NPs and validate cellular targets critical for informing efficacious strategies for EAC prevention or interception.

Public health relevance
PROJECT NARRATIVE Multiple lines of evidence support that IL-8, a proinflammatory and immune suppressive chemokine, is an early key driver of esophageal adenocarcinoma (EAC) progression. EAC is a growing health problem characterized by rising incidence, substantial morbidity, and poor prognosis (5-year survival rates <20%) supporting the urgent need for improved strategies for prevention and interception. The goal of this proposal is to identify and screen non-toxic natural products that inhibit the progression of premalignancy to EAC through targeting IL-8 signaling.